Endowment for Disparities Research

DESCRIPTION (provided by applicant): As we begin a new millennium, the nation is challenged by the persistent need to eliminate major health status disparities between different segments of the population. Investment in biomedical research has brought the elimination of some devastating diseases, but health disparities remain. Meharry Medical College's history and vision for the future place it in the forefront of efforts to ameliorate health status disparities affecting the African American community and other underrepresented minorities. Meharry's School of Medicine research strategic plan places emphasis on strategies designed to foster an increase in health related research and competitiveness of investigators through faculty development and enhancement of the research infrastructure at the College. The three major goals of the College's research strategic plan are: 1) Increase the number of basic and clinically trained research scientists; 2) Enhance the competitiveness of basic and clinical researchers at Meharry Medical College through strengthening the research infrastructure capacity of the College; 3) Augment and strengthen the College's research capabilities through the development of thematic focused health disparity interdisciplinary Centers of Excellence. This proposal seeks endowment funds in support of the College's efforts to: advance the scientific understanding of health disparities; develop new or improved approaches to control or prevent diseases and disabilities that contribute to health disparities; and, develop culturally sensitive evidenced-based approaches to treat diseases and conditions that disproportionately affect African-Americans. The complementary specific aims of this proposal are: l) To establish an Endowed Chair in Oncology to strengthen the College' s recruitment efforts of a "magnet scientist" to lead the development and advancement of Meharry' s cancer program; and 2) To strengthen the fellowship program for clinical faculty members who enroll in the Master of Science in Clinical Investigation program.